Neuroinflammation as a Mechanism Linking Early Life Stress, Altered Functional Connectivity, and Anhedonia in Major Depression

PROJECT SUMMARY/ABSTRACT
Stressful life events are one of the strongest predictors of depressive symptom onset, and individuals exposed
to early life stress (ELS) are 2 to 4 times more likely to meet diagnostic criteria for major depressive disorder
(MDD). Anhedonia, or deficits in motivation, effort, and pleasure, is a core feature of MDD, and ELS has been
implicated as a significant contributor in the pathophysiology and manifestation of anhedonia, which may
explain higher rates of MDD in ELS. It is postulated that ELS increases anhedonia risk by potentiating cross-
talk between the innate immune system and neural circuits implicated in threat- and reward-related processing.
In support of this framework, there is evidence linking inflammation to increased vigilance for threats and
dampened reward sensitivity. Experimentally-induced inflammation alters activation of threat- and reward-
related brain regions, namely the amygdala and ventral striatum (VS). Further, higher levels of peripheral
inflammation have been associated with reduced functional connectivity between the ventromedial prefrontal
cortex (vmPFC) and amygdala, as well as the vmPFC and VS, which in turn is associated with decreased
motivation and anhedonia, particularly in ELS-exposed individuals. Additionally, associations between
inflammation and anhedonia have been observed in PET studies of patients with MDD using radioligands to
target the 18-kDa translocator protein (TSPO), whose expression is increased in classically-activated
microglia. However, prior research on ELS and anhedonia in humans lacks direct measures of
neuroinflammation, and studies have rarely focused on integrating measures of reward- and threat-related
neural connectivity. Thus, the goal of the proposed project is to advance a stress-induced model of anhedonia
that is driven by threat- and reward-related neuroinflammatory mediators. We propose to collect simultaneous
PET-fMRI from unmedicated MDD patients with clinically significant anhedonia and matched healthy controls
using the radioligand [18F]PBR111 to assess TSPO expression, an index of neuroinflammation. In Aim 1, we
will test the impact of early life stress on neuroinflammation (TSPO binding) in threat- and reward-related brain
regions. Across both groups, we hypothesize that greater exposure to ELS will predict increased TSPO binding
in brain regions implicated in reward and threat processing. In Aim 2, we will test the impact of ELS on threat-
and reward-network task-based functional connectivity. Across both groups, we hypothesize that greater
exposure to ELS will predict decreased threat-network functional connectivity (e.g., amygdala-vmPFC) and
decreased reward-network functional connectivity (e.g., VS-vmPFC). In Aim 3, we will evaluate the impact of
ELS on anhedonia severity via neuroinflammation and altered functional connectivity in MDD. In the MDD
group, significant pathways will be explored using mediation analyses. Findings will yield preliminary evidence
of ELS-related neuroinflammation, test putative immune mechanisms underlying the association between ELS
and anhedonia, and advance our understanding of anhedonia as a transdiagnostic symptom.

Public health relevance
PROJECT NARRATIVE Childhood and adolescence comprise a vulnerable period for the developing brain, and long-term exposure to early life stress (ELS) causes distinct neurobiological changes that persist throughout the lifespan. The present study uses PET-MR imaging to test an ELS-induced model of anhedonia in major depressive disorder that is driven by threat- and reward-related neuroinflammatory mediators. It is critical to clarify the pathophysiological mechanisms by which ELS confers risk for psychopathology to hasten the development of mechanism- informed interventions to prevent or reduce negative health outcomes.